Endogenous drivers of endothelial inflammation in Alzheimer's Disease

PROJECT SUMMARY
Senescent cells (SnCs) accumulate in tissues with increased organismal age. SnCs have been associated with
multiple age-associated chronic diseases and implicated as contributing pathological factors in Alzheimer’s
disease (AD). Brain vasculature aging contributes to AD progression and vascular dysfunction is observed early
on in the disease. Recent studies suggest that endothelial senescence impairs the barrier function of the brain
endothelium. However, SnCs within the brain vasculature have not been studied in the context of AD. I examined
multiple human and mouse single-cell RNA-seq datasets from organisms of different ages to create a resource
that identifies SnCs in different cell types and tissues. My preliminary data indicate that the brain vasculature
has an increased SnC burden in AD and that the blood-brain barrier expresses receptors for SnC signaling.
However, the phenotype and molecular signatures of AD-associated SnCs have not been resolved. I hypothesize
that senescent brain vascular cells have distinct and targetable molecular patterns and that their disruptive effect
on healthy vascular cells can be lessened by interrupting specific SnC signaling pathways. Moreover, I have
shown that transposable elements and human endogenous viral elements are upregulated in endothelial
inflammation, cellular senescence, and AD. Transposable elements differentially regulated in endothelial
inflammation were co-expressed with important inflammatory and senescence regulators, such as NFKB and
CDKN2A. I hypothesize that transposable elements expressed during inflammation and senescence contribute
to sterile inflammation and loss of blood-brain barrier integrity. I will transcriptionally characterize SnCs within
the brain vasculature of human AD patients and mouse models by examining existing single-cell AD datasets. I
will find unique patterns of mRNA expression, regulatory mechanisms, and cell-cell interactions specific to AD-
associated SnCs. I will train a semi-supervised convolutional neural network to identify senescent cells within
the AD brain vasculature. I will test how SnC signaling contributes to AD by ablating receptors required in SnC
signaling in brain microvascular endothelial cells with CRISPR-Cas9 then test the effect on barrier integrity in
the presence of SASP molecules. Next, I will find transposable elements uniquely expressed in senescent brain
endothelial cells and bystander cells during AD. I will uncover regulatory mechanisms within the cells that
contribute to the aberrant activation of transposable elements and examine the pathways these elements
activate that contribute to barrier dysregulation. I will test how shRNA knockdown of expressed transposable
element RNA affects the inflammatory and barrier phenotypes in brain endothelial cells. The proposed studies
will teach me multiple computational approaches, such as machine learning, as well as advanced genetic
manipulation in cells and animal models.

Public health relevance
PROJECT NARRATIVE Senescent cells accumulate in the brain vasculature over time which contributes to inflammation, barrier leakiness, and Alzheimer’s Disease. Our experiments will uncover how senescent cells communicate with their environment and examine how aberrant activation of ancient endogenous sequences contributes to their deleterious effect. We hope to find new treatments for Alzheimer’s Disease by restoring the health of the brain's blood vessels.